Temporal associations between systemic inflammation, cardiovascular risk profile and development of Alzheimer’s disease and related dementias in patients with rheumatoid arthritis

PROJECT SUMMARY/ABSTRACT
This K24 application seeks to provide protected time for Dr. Elena Myasoedova to mentor trainees in patient-
oriented research (POR) aiming at defining the long-term temporal relationship between systemic inflammation,
cardiovascular risk factors and cardiovascular events on the risk of Alzheimer’s Disease and other related
dementias (ADRD), using rheumatoid arthritis (RA) as a prototype. This award will enable the applicant to solidify
and advance her current NIA-funded R01 research program in new directions and to expand her mentoring
opportunities and mentoring experience. Dr. Myasoedova is a tenure-track Associate Professor at Mayo Clinic.
She has a strong and ongoing record of high-quality POR, publication, and mentoring in research directly related
to the proposed studies. The applicant has shown significant abilities in mentoring trainees at all career stages
and will continue to benefit from the rich and robust resources, unique research infrastructure and a large pool
of patients and mentees at Mayo Clinic. During the funding period, further development of the applicant will
include: 1) Improvement in mentorship skills in POR; 2) Enhancement of knowledge in biostatistics for POR; 3)
Development of a collaborative niche for POR in aging and ADRD in rheumatic diseases; and 4) Maintaining
uninterrupted extramural funding. These goals will be achieved through a combination of seminars, meetings,
courses, and collaboration with the Division of Epidemiology, the Kogod Center on Aging, the Rochester
Epidemiology Project and the Mayo Clinic Study on Aging. Dr. Myasoedova will further integrate and advance
these skills through continued mentorship of trainees within currently funded POR and through expansion of her
ADRD research through the K24 mechanism. Research aims of the proposal include: 1) Examining the temporal
association between cardiovascular risk factors, systemic inflammation and ADRD in RA; 2) Evaluating direct
and cardiovascular-mediated effects of chronic inflammation on ADRD in RA; and 3) Defining the population
attributable risk (PAR) of RA characteristics on incident mild cognitive impairment and ADRD, overall and by
sex. The proposed studies will inform risk stratification of ADRD in a chronic inflammatory setting of RA overall
and by sex as a key step for advancing the understanding of ADRD risk and developing prevention strategies in
patients with RA and beyond. These aims are well-aligned with NIA’s Goal D to improve our understanding of
the aging brain and ADRD, specifically defining the impact of inflammatory processes on the development of
AD, and whether systemic risk factors such as obesity, diabetes, hypertension, and heart disease during midlife
are associated with accelerated age-related cognitive decline and with increased risk for AD. Successful
completion of this award will facilitate the development of the next generation of patient-oriented researchers in
ADRD and will expand Dr. Myasoedova’s POR program to ensure continued mentoring opportunities into the
future, aligning with the NIA’s mission to “Foster the development of research and clinician scientists in aging’.

Public health relevance
PROJECT NARRATIVE This application has high public health importance because it will: 1) support mentoring of junior investigators in patient-oriented research (POR) with a focus on the association between systemic inflammation and cognitive decline, thus aligning with the NIA’s mission to “Foster the development of research and clinician scientists in aging’; and 2) define role of inflammation and cardiovascular risk factors in risk of Alzheimer’s disease and related dementias (ADRD), in order to inform risk stratification and future interventions on primary prevention of ADRD. The aims of the application perfectly align with the NIA’s goal of defining the impact of inflammatory processes on the development of AD and are directly relevant to the NIH’s mission to foster innovative research strategies and their applications to protect and improve public health.